EVALOF IMMUNE STATUS FOLLOWING THE ADMINISTRATION OF CHEMOTHERAPY OR STEROIDS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This study is designed to collect preliminary data on the effects of chemotherapy or steroid treatment on cytokine levels and T, B, and natural killer cells. No experimental drug will be administered. Participants will be enrolled based on their standard of care chemotherapy or steroid regimen. The primary endpoints are: (a) to measure cytokine levels in serum, and (b) to determine the number of T, B, and NK cells at different timepoints following administration of chemotherapy or steroids.